Training a new generation of biologists in quantitative bioimaging with Microtutor

Project Summary
Despite extraordinary technological advancements in biology, light microscopy remains
unrivaled for observing cell behavior at scale and at different scales, ranging from the structure
and kinetics of subcellular molecules, over whole tissues, to the dynamics of entire developing
organisms. This ability to visualize single cells, track samples over time, and detect interactions
has made it a critical tool for scientific discovery. Light microscopes are also widely accessible,
with ~44% of NIH “Shared Instrumentation” (S10) grants from 2013-2022 awarded for
“Biomedical Imagers” or “Optical Instruments” (NIH ORIP). However, microscopy’s historical use
as a qualitative tool means the potential to combine it with bioimage analysis for high-quality,
quantitative data remains underutilized. This is particularly evident in bioimage analysis, where
many trainees report low computational proficiency and discomfort in developing these skills.
Current training is often self-directed, leading to inconsistent quality and expertise distribution.
This has created a serious gap in biomedical research training. We recently launched
Microtutor, an innovative online platform that leverages interactive learning technologies for
microscopy and bioimage analysis education. Using H5P, the platform connects short video
lessons with interactive demonstrations and frequent mastery assessments. Curated by experts
across the nation, the content encourages exploration through interactive visualizations. This
proposal aims to expand Microtutor by adding new modules on microscopy best practices and
bioimage analysis to address the growing community need. We will integrate state-of-the-art
open-source image analysis tools like Piximi, further enhancing Microtutor’s role as a
comprehensive resource for modern microscopy and bioimage analysis education.
Additionally, we will utilize the course’s virtual, self-paced nature to offer nationwide
“flipped-classroom” sessions, partnering with colleges and universities to host live Q&A
sessions and guest speakers, making expert-led learning accessible to all researchers. With the
increasing types of large-scale microscopy applications—such as light sheet microscopy, spatial
transcriptomics, and high-throughput multiwell plate imaging—there has never been a more
critical time to ensure researchers follow best practices and interpret data effectively.
Microtutor’s flexibility and power will allow experts in microscopy and image analysis to share
this knowledge with the entire NIGMS community and raise the quality of bioimaging research in
hundreds of laboratories nationwide and meet a significant need in the biomedical research
workforce.

Public health relevance
This project will create Microtutor, an interactive online platform that provides biomedical researchers with critical training in microscopy and bioimage analysis. By improving data quality and accelerating discovery, Microtutor will strengthen studies of disease mechanisms and speed the development of new diagnostics and treatments, thereby advancing public health.